Inner ear infection and innate immunity

ABSTRACT
The inner ear is perfused by vessels that provide oxygen and nutrients to support the activity of hearing.
This separation between the blood and inner ear fluids is maintained by tightly connected cells that
reinforce the blood vessels and ensure that small molecules, proteins, and cells remain inside the blood
vessel. The structural elements that form this barrier are called the blood-labyrinth barrier. This barrier
plays an important role in regulating the entry of white blood cells from the blood stream into the inner
ear. When the immune system is activated, this barrier becomes leaky, and white blood cells leave the
vessel lumen, enter the inner compartment, and can then eliminate germs or unwanted cells. These
white blood cells are also capable of damaging normal tissues that are not intended targets of the
inflammatory response. The first part of this study examines the developing blood-labyrinth barrier in
animals that are born with a viral infection called cytomegalovirus (CMV). CMV is an important cause of
hearing loss in the newborn population and we do not fully understand how it causes hearing loss. We
have limited options to address hearing loss in infants born with CMV. This infection occurs at a time
when the blood labyrinth and blood brain barriers are not yet mature. Infection that begins in utero
cause long term deficits that may be related to abnormal development of these vascular barriers.
The second aim will identify which cells are directly targeted by the virus and whether cell killing by viral
infection contributes to loss of hearing function.
The third group of experiments will explore the role of the interferons in contributing to hearing loss in
mice. We will explore the effects of reducing IFN signaling specifically in blood vessels after viral
infection to disrupt the events that could lead to hearing loss while maintaining the important antiviral
effects of IFNs.
The goal is to improve our understanding of how the immune system works in the inner ear, what
elements of the immune system are critical for preventing or eliminating infections, and which of its
functions might contribute to damage and hearing loss. Immunosuppressive and anti-inflammatory
agents have been used in cases of sensorineural hearing loss with success, but their side effects limit
their effectiveness. Thus, there is an opportunity to study the contributions of inflammation and immunity
to design better medications and improve treatment of progressive hearing loss.

Public health relevance
PROJECT NARRATIVE: When the cochlea is injured or infected, immune cells exit the blood vessels and enter the fluid spaces of the cochlea. How normal vascular barriers exclude these cells from the inner ear during times of health and how these barriers open to allow passage of immune cells when they are needed, is not known. We will explore how vessels control traffic of these cells, how the opening and closing of the barrier occurs, what cells in the cochlea are susceptible to virus, and what steps lead to irreversible damage and hearing loss after viral infection in the inner ear. Because viral infection in utero is a well established condition that frequently leads to hearing loss, we choose to study the effects of congenital viral infection on the blood labyrinth barrier and auditory development and determine how these two may influence each other.